Administrative Core

Administrative Core (Core C) – Rutgers, The State University of New Jersey, RBHS
Project Summary
Core C is the administrative core for the PPG program and resides within the Rutgers Institute for Translational
Medicine and Science (RITMS) at Rutgers University. The RITMS, directed by Dr. Panettieri, is an Institute in
Rutgers Biomedical and Health Sciences unit at Rutgers University and focuses on translational and clinical
science of chronic disease. Over the past four years, Core C has played an integral role in the coordination of
the fiscal services and scientific communication among institutions, projects and cores. Although the
administrative staff for Core C changed with Dr. Panettieri’s move from the University of Pennsylvania to Rutgers
University, the transition of the program and its productivity remains high. This Core has three specific
aims/goals. Aim 1 addresses the administrative requirements of the Program. These services will be provided
by dedicated business and secretarial personnel who are currently RITMS staff. The staff will handle the day-
today operational needs of the program and includes two grants/financial experts and clerical staff. In Aim
2, Core C will facilitate and coordinate the scientific interactions and communication among the individual
components of the PPG program. These include state-of-the-art videoconferencing, electronic laboratory
notebook access and scheduling/coordinating work in progress and steering committee meetings and
annual retreats. In Aim 3 the administrative core will coordinate peer review of scientific progress. This will
be accomplished through semi-annual meetings of the internal advisory board, consisting of senior Rutgers
University-, Thomas Jefferson University- and University of South Florida-based investigators, and every-other
year meetings of the external advisory board,consisting of renowned scientists. This critical core will ensure
the efficient functioning of the project and will facilitate maximum scientific productivity of the program.

Public health relevance
Administrative Core (Core C) – Rutgers, The State University of New Jersey, RBHS Project Narrative Core C will provide fiscal and administrative infrastructure for the PPG. This core will facilitate communication among participants and ensure dissemination of scientific progress to the research and lay communities.